Role of distinctive cortical motor maps for hand muscles for recovery post stroke

PROJECT SUMMARY / ABSTRACT
The objective of the parent grant (R01 HD094731) is to determine if combining TheraBracelet with hand task
practice is superior to hand task practice alone for recovery of hand function post-stroke in an adequately
powered study. The parent grant aims to determine the effect of TheraBracelet on hand functional recovery,
sensorimotor grip control, and neural communication within the cortical sensorimotor network. The proposed
diversity supplement aligns nicely with the scope and approved aims of the parent award as the supplement
aims to investigate neuroplasticity toward distinctive cortical motor maps for hand muscles that may contribute
to motor recovery. Specifically, the supplement aims to determine the effect of rehabilitation intervention on
spatial distinctiveness among motor maps of hand muscles as measured using transcranial magnetic stimulation
(TMS) and determine the relationship between motor map changes and motor recovery. This supplement
research is expected to inform the new insights for the mechanism for recovery of the fine motor control of the
hand following stroke. This new knowledge will be critical for the development of novel rehabilitation treatments
that facilitate the cortical neuroplasticity necessary to achieve hand motor recovery. Most importantly, this award
will foster the underrepresented minority candidate (Ms. Arianna Alston) for a PhD neuroscience research career.
The training activities will focus on developing new research skills for Ms. Alston to perform the supplement
research and begin her research career. Specifically, Ms. Alston will (1) enhance her knowledge of neuroscience
applied to neurorehabilitation research, (2) develop proficiency in collecting, analyzing, and interpreting TMS
motor maps for corticospinal neuromuscular control, and (3) develop a successful application for a PhD program.
Therefore, this supplement award will contribute to enhancing diversity in the biomedical workforce, as only 7%
of doctoral degree recipients in science and engineering disciplines were African American, whereas African
Americans make up 12% of the total US population between the ages of 18-74 according to NSF report.

Public health relevance
PROJECT NARRATIVE The proposed diversity supplement aims to determine how rehabilitation treatment results in separation of multiple hand muscles’ representations in the brain and how this separation relates to recovery of dexterous hand function in stroke survivors, thus informing the new insights for the way the brain changes to improve hand function after a stroke. Hand function is difficult to regain after a stroke; the new knowledge obtained from this work is expected to contribute to the development of novel rehabilitation treatments to facilitate change in the brain as necessary to improve recovery of hand function for stroke survivors. This supplement also will foster development of the underrepresented minority candidate toward a researcher career in rehabilitation research and to enhance diversity in the biomedical workforce.